Northwestern University Allergy and Immunology Research (NUAIR) Program

PROJECT SUMMARY
The overall aim of the Northwestern University Allergy-Immunology Research (NUAIR) Program is to train
postdoctoral scientists in translational research, defined as research of disease mechanisms that includes
investigations in human subjects, using human samples or appropriate pre-clinical models of disease. The
NUAIR Program builds on our Allergy and Immunology Fellowship, which has a long history of excellence in
clinical and academic training. Unified efforts of established investigators in our Division with those from other
Divisions and Departments have created a rich environment for translational research in the NUAIR program.
This program enables clinical and basic researchers, both faculty and trainees, to collaborate and interact in
weekly research and didactic activities. These collaborations have led to multidisciplinary translational research
programs for several allergic diseases supported by well-equipped laboratories, many excellent research cores
and facilities, and institutional resources and initiatives. Under the NUAIR Program, a steady state of four highly
competitive MD, MD/PhD, and/or PhD postgraduate trainees per year will receive 2 years of translational
research training. Each will receive mentoring in clinical and basic research to study mechanisms of allergic and
immunological diseases. The mentors in our program were carefully selected based on their track record of
publications, awarded grants, mentoring, collaboration, and translational research interests that matched the
needs of the program. In addition to well-structured research training, mentoring and didactic activities, close
evaluation of trainees’ needs and performances will ensure proper progress during training. Over the course of
this grant, 30 trainees have been successfully mentored. The majority of matriculated trainees assumed
academic or research positions. Our retention plan includes support for select trainees who remain in our Division
as junior faculty members after T32-supported training, while seeking external funding support. Senior faculty
members in the Allergy and Immunology Division have a strong record of mentoring NUAIR trainees towards
obtaining K awards and independent R grants. We also offer programs to inspire medical students and residents
to pursue careers in Allergy and Immunology. Taken together, our rapidly expanding and comprehensive Allergy
and Immunology research environment provides state-of-the-art training for highly qualified MD, MD/PhD and
PhD postdoctoral trainees. These trainees will conduct collaborative translational research in Immunology,
initiating research careers that will help solve the critical national need for academic leaders in this field.

Public health relevance
PROJECT NARRATIVE The Northwestern University Allergy and Immunology Research (NUAIR) T32 Fellowship program is designed for MD, MD/PhD and/or PhD trainees with an interest in advanced training in translational research in the field of Allergy-Immunology. Trainees have access to renowned mentors in both clinical and basic science departments in order to develop a mentoring team with expertise in both realms to advance their training and develop innovative and impactful projects. NUAIR has been successful in training academic investigators during its first three funding cycles and aims to continue this record to develop the next generation of translational immunologists.